Investigating the mechanism of infection and therapeutic potential of Pseudomonas nucleus-forming phages

Project Summary
Nucleus-forming bacteriophages (phages) are a recently discovered class of lytic phages that protect
their genome by encapsulating it in a nucleus-like protein shell (phage nucleus). The goal of the proposed
research is to determine whether the unique properties of nucleus-forming phages make them advantageous
therapies for human Pseudomonas aeruginosa infections. ΦKZ and ΦPA3 are nucleus-forming phages that
infect P. aeruginosa and demonstrate the ability to selectively localize proteins to their phage nucleus and
exclude others, including DNA-targeting bacterial phage defense proteins. Preliminary data show that ΦKZ
gp69 is a conserved protein in P. aeruginosa nucleus-forming phages and plays a key role in mediating
selective protein trafficking into the phage nucleus. This research will determine the structure of gp69 in
complex with other nuclear shell-associated proteins, the mechanism by which gp69 mediates protein transport
into the phage nucleus, and other factors that facilitate transport into the phage nucleus. Furthermore, this
research will determine the motifs that signal a protein to be imported into the phage nucleus, how those motifs
differ between P. aeruginosa infecting phage, and the competitive advantages selective protein import imparts
on nucleus-forming phages. Lastly, resistance to phages is known to select for costly evolutionary trade-offs in
the host bacterium. This research will determine how pathogenicity and antibiotic sensitivity are altered in P.
aeruginosa resistant to nucleus-forming phages. Together, the results of this study will provide crucial
information for the development of nucleus-forming phage therapeutics.

Public health relevance
Project Narrative Multidrug-resistant Pseudomonas aeruginosa infections are a critical public health threat and a desired target for bacteriophage therapy. Nucleus-forming bacteriophages are a recently discovered class of bacteriophage with high therapeutic potential due to their lytic nature and intrinsic resistance to multiple bacteriophage defense systems. The research in this proposal will determine the genetic, biochemical, and structural basis for protein import into the phage nucleus, as well as how these bacteriophages affect pathogenicity and antibiotic sensitivity in P. aeruginosa.